Contextual Word Learning in Children with DLD

PROJECT ABSTRACT
Vocabulary achievement impacts important life outcomes such as academic success, vocational options, and
earning potential. Developmental language disorder is a common disorder which impacts word learning, both
when words are directly taught and when words are learned implicitly after multiple contextual encounters.
Contextual word learning is the most common situation in which words are learned, and this typically occurs
while reading. As such, interventions which increase the effectiveness of contextual word learning have the
potential to meaningfully alter the trajectory of vocabulary growth.
The long term objective of this research program is to develop effective interventions for children with
developmental language disorder, which target contextual word learning while reading. The overall aim of this
study is to test the effectiveness of an intervention which combines two approaches known to be effective in
typical development: metalinguistic training about semantic inferencing, and use of multiple texts with high
semantic diversity. Semantic diversity refers to the range of semantic content in texts which contain the novel
words. In Aim 1, we test the effectiveness of this novel intervention in children with typical development (n=50),
and in Aim 2, we evaluate its effect in children with developmental language disorder (n=50). Participants will
complete a three session metalinguistic intervention involving repeated meaning generation, explanation about
proposed meanings, and feedback about accuracy. The quality of semantic inferencing about novel words
which are untreated (not involved in the intervention) will be measured pre- and post-intervention as a measure
of the effect of intervention on the skill of semantic inferencing. Measures of retention of the semantics of
words used in intervention will be taken one week after each session, and are expected to increase with more
exposure to the metalinguistic intervention. Within sessions, words will be presented in three different semantic
diversity contexts: no diversity (repeated stories), medium diversity (unique stories with the same global
context), and high diversity (unique stories with different global contexts). Based on prior research about the
effect of semantic diversity on word learning in children and adults, we predict that measures of retention of the
semantics of words used in intervention are expected to be highest in the high semantic diversity condition.
Results from this study will be used to support an application for a fully powered randomized controlled trial of
a contextual word learning intervention for children with DLD, and will inform best practices for children with
typical development. The project is innovative because we will examine contextual word learning in
developmental language disorders, we will combine two treatment approaches in a novel way, and because
we focus not only on the effect on treated words, but also on generalization of the skill of semantic inferencing.

Public health relevance
PROJECT NARRATIVE Many children have developmental language disorder, which makes it difficult to learn language, including vocabulary, and results in ongoing academic and social difficulties. Despite the fact that most words are learned in context without direct teaching, we know very little about how children with developmental language disorder learn words in context. This project will combine, for the first time, two strategies which improve contextual word learning in children with typical development, and test their effect in both typically developing children, and those with developmental language disorder. The results will provide timely information that will contribute to evidence based practice for contextual word learning in children with developmental language disorder.